Arkansas Center for Food Allergy Research (ArCOFAR)

PROJECT SUMMARY
Despite significant research advances, many remaining questions must be addressed before global
implementation of impactful therapeutic and prevention options for patients affected by food allergy can be
realized. In response to NIAID’s RFA for the Consortium for Food Allergy Research (CoFAR), the Arkansas
Center for Food Allergy Research (ArCOFAR) will build on its >30-year foundation of expertise and leadership
in food allergy to address CoFAR’s overarching program goals. The ArCOFAR site is ideally positioned to
function as a CoFAR Clinical Research Center (CRC). In addition to our extensive research experience,
distinguished by key contributions in advancing food allergen immunotherapeutics for peanut allergy and
eosinophilic gastrointestinal disorders (EGID), we will capitalize on our population’s distinctive geographic and
patient demographic characteristics. Namely, we serve a largely rural, widely dispersed, and underserved
population in which more than 50% are under-represented minorities and earn below $50,000 annually, and 33%
have earned only a high school diploma or below. This study participant population stands to contribute
significantly to the nationwide participant pool and to increase our understanding of allergy across a broad
demographic spectrum. Our efforts will be directed by the central hypothesis that ArCOFAR will measurably
impact patients with food allergy and related disorders through expertly designed, innovative clinical
trials using novel approaches that can advance translation of treatments and prevention strategies to
practice, while training the next generation of researchers. Our overarching goal is to provide a
comprehensive, collaborative research platform to measurably improve the lives of children and adults with food
allergy and related disorders. The studies proposed in this application highlight ArCOFAR’s strengths with a new
peanut peptide-based treatment approach to peanut allergy; evaluation of treatment response biomarkers in
EGID; and integrative research in food science, nutrition, and food allergy. Our hypothesis will be tested by
executing the following Specific Aims: 1) Expand therapeutic trials participation among food-allergic patients with
racial/ethnic diversity and for those living in rural, underserved regions by designing and implementing novel,
disease-impacting clinical trials; 2) Increase center-specific research into new focus areas of discovery that also
have capacity for expansion to larger, multi-center investigation; and 3) Promote career development of new and
early-career researchers into food allergy by linking established research mentors and new investigators through
direct engagement in center-specific projects. In these efforts we will coordinate appropriately with the CoFAR
network and participate in the CoFAR-wide clinical trial. This proposal’s outcomes will be to improve the health
of children and adults with food allergy in Arkansas and beyond while advancing CoFAR’s mission to
fundamentally transform food allergy research and treatment.

Public health relevance
PROJECT NARRATIVE Despite significant clinical and research advances in the field of food allergy, many remaining questions must be addressed before global implementation of impactful therapeutic and prevention options for patients affected by food allergy can be realized. The Arkansas Center for Food Allergy Research (ArCOFAR) builds on a >30 year foundation of expertise, and leadership in food allergy and is ideally positioned to function as a Clinical Research Center within the Consortium for Food Allergy Research. We will contribute our extensive research experience and capitalize on our population’s distinct geographic and patient demographic characteristics to immediately address the overarching program goal of the Consortium for Food Allergy Research to improve the health of children and adults living with food allergy and related disorders.